ENERGY EXPENDITURE, DIETARY INTAKE AND FEEDING PRACTICES FOR PRETERM INFANTS

This study is designed to assess the energy expenditure, adequacy of the diet, and inflammatory processes for extremely low birth weight infants with a history of lung disease beginning with the period of enteral feeding in the NICU and continuing through the first eight months, post-term age. The goal is to use these findings for the design of an intervention to support appropriate infant-feeding practices, nutritional intake, growth, and development.